ADVANCING ANTI-RACISM, DIVERSITY, EQUITY, AND INCLUSION IN STEM ORGANIZATIONS: A CONSENSUS STUDY

Source: https://www.nationalacademies.org/our-work/advancing-anti-racism-diversity-equity-and-inclusion-in-stem-organizations-a-consensus-study The National Academies of Sciences, Engineering, and Medicine (NASEM) will convene a national summit that will highlight how racism operates at different levels in science, technology, engineering, math, and medicine (STEMM) An interdisciplinary committee of experts will develop a cohesive report with recommendations for actionable antiracist mechanisms to advance diversity, equity, and inclusion. The final consensus report will review research and evidence in which racism and bias conditions create systemic barriers and impede STEM careers for historically marginalized racial/ethnic groups; identify principles for sustainable organizational culture change to address racism and promote diversity, equity, and inclusion; synthesize existing research on methods to improve recruitment, retention, and advancement; identify examples of effective strategies to advance anti-racism in STEM organizations; define a research agenda to address gaps to advance anti-racism, diversity/equity, and inclusion.